Role of endothelial Sox17 in EC-SMC crosstalk and homeostatic regulation of blood vessel adaption to arterial hemodynamics

SUMMARY
Arteries and veins play different roles in human physiology and vascular diseases. Notably, arterial and venous
endothelial cells (ECs) demonstrate distinct molecular profiles. The establishment of such molecular distinction
is orchestrated by series of transcriptional programs, which have been well studied in developmental biology.
However, how these EC transcriptional programs control adult blood vessel structure and function, and how to
translate this knowledge into clinical application such as vein or tissue engineered graft adaptation is under-
explored. To address this question, we examined the transcription profile of arterial vs. venous ECs in adult
blood vessels and have identified several key transcription factors that are differentially expressed in arterial
vs. venous ECs. Among them, Sox13 and Sox17 are highly expressed in adult arterial ECs but not in venous
ECs. Our preliminary studies demonstrate that over-expressing Sox17 in venous ECs reconstitutes all the
known arterial markers, suggesting Sox17 is a key regulator of adult arterial EC phenotypes. Importantly,
Sox17 induces the expression of multiple families of molecules (Notch, Ephrin, Connexins, PDGF) that may
confer signals from ECs to smooth muscle cells (SMCs) to regulate SMC phenotypes in blood vessels. EC
Sox17 also promoted SMC contractile phenotype in EC-SMC co-culture and graft remodeling model. On the
other hand, over-expressing Sox13 in ECs facilitates the recruitment of SMCs toward blood vessels. Based on
these encouraging preliminary data, we hypothesize that endothelial Sox13/17 play synergistic roles in the
homeostatic regulation of adult artery functions by maintaining adult arterial EC phenotype and engaging EC-
SMC crosstalk. To test this hypothesis, we will investigate how the endothelial Sox13/17 regulates EC and
SMC phenotypes and their role in blood vessel structures and functions using in vitro bioengineered models as
well as in vivo animal models.

Public health relevance
Narrative (Public health relevance) This project will investigate whether introducing endothelial Sox13/17 will improve blood vessel adaptation to arterial environment. It has broad impact to vascular diseases where the homeostatic remodeling is impaired such as hyperplasia, stenosis, aneurysm, vein graft adaptation, as well as designing better tissue-engineered vascular grafts.